Enhancing PALM with novel statistical methods, cloud integration, parallelization, and imaging standards

PROJECT SUMMARY
Statistics is the staple of all biomedical research. Yet, most existing statistical methods and software packages
do not trivially extend to the analyses of datasets of the unprecedented size and level of detail as those being
collected and made publicly available by the BRAIN Initiative and by the NIH Blueprint for Neuroscience
Research. These datasets include the Adolescent Brain and Cognitive Development Study (ABCD) and the
Human Connectome Project (HCP), among others. Dense phenotyping in these studies creates many
opportunities for generation and testing of hypotheses about brain structure and function in health and disease.
However, the lack of availability of flexible statistical methods that accommodate large-scale inferences, and the
lack of suitable implementations even when such methods exist, hinders our ability to integrate data across
different domains, scales, and representations used for study. This project is intended to modify the free and
open-source analysis tool PALM (Permutation Analysis of Linear Models), augmenting its abilities to allow
researchers to explore voluminous amounts of data using optimal and valid statistical methods, with minimal
assumptions, and with a fast implementation that makes rigorous permutation tests computationally accessible.
PALM already offers several important approaches and features not available in any other software, and has
become a popular tool in brain imaging. The goals of this project are: (1) develop and implement a general
approach to conduct analyses of repeated measures (longitudinal) and of genetic (familial) data using
permutation tests, with an emphasis on BRAIN Initiative data; (2) develop and implement novel test statistics
that are sensitive to spatial and temporal processes across the brain, even for data measured in different
domains, scales, and representations; (3) expand PALM’s multivariate capabilities, to uncover statistically
independent latent factors from multiple dimensions (e.g., cellular, behavioral, genetic, or imaging) that can span
multiple disease categories; (4) disseminate existing and novel statistical methods with fast and efficient software
implementation that makes use of parallelization when multithreading, graphics processing units (GPUs) and/or
high performance computing systems (HPCs) are available, (5) ensure that PALM is compatible with recently
developed data models and standards used by the BRAIN Initiative, and (6) ensure that PALM can be integrated
with cloud repositories that host large datasets. The development of novel theory and algorithms will consider
computational efficiency, standardized data models, and the hardware architectures available.

Public health relevance
PROJECT NARRATIVE Many important studies that collect detailed data about brain are ongoing. The large size and complexity of this data imposes a challenge to existing methods of analysis. This project proposes 3 improvements to the way such data can be statistically analyzed, and proposes 3 modifications to a popular research software package, called PALM, that will enable the use of fast, powerful computers to analyze these data.